Children's Tumor Foundation 2016 Neurofibromatosis (NF) Conference

Children’s Tumor Foundation 2016 NF Conference PI: Michael Fisher, MD PROJECT SUMMARY/ABSTRACT The Neurofibromatosis (NF) Conference is recognized as the premier annual scholarly gathering of international NF researchers and physicians. The Conference is organized by the Children’s Tumor Foundation and thought leaders in the fields of neurofibromatosis type 1 (NF1), neurofibromatosis type 2 (NF2) and schwannomatosis. The agenda of the conference is designed to provide education about best clinical practices for these rare genetic tumor syndromes, opportunities to share major advances in research and sessions that support the development of new collaborations and the growth of new investigators. The research landscape in NF1, NF2 and schwannomatosis has been remarkably dynamic in the last 5 years and this conference is a critical venue for the presentation and integration of basic science discovery, translational data and outcomes from clinical trials in a meaningful way to both enhance the quality of ongoing research and improve current clinical care. Children’s Tumor Foundation 2016 NF Conference PI: Michael Fisher, MD

Public health relevance
Children’s Tumor Foundation 2016 NF Conference PI: Michael Fisher, MD PROJECT NARRATIVE The Children’s Tumor Foundation Neurofibromatosis (NF) Conference is the major international venue for sharing the key advances in research discovery and clinical management guidelines for neurofibromatosis type 1 (NF1), neurofibromatosis type 2 (NF2) and schwannomatosis. It is also the forum in which new investigators form collaborations with scientists within the NF field. The 2016 conference is designed to address all of the nodes in the therapeutic pathway pertinent to NF from basic discovery, through translational science, to clinical trial design and implementation. Children’s Tumor Foundation 2016 NF Conference PI: Michael Fisher, MD